The role of TRAIL in immune control of cytomegalovirus

Summary
Cytomegalovirus (CMV, a b-herpesvirus) establishes a persistent infection that is endemic in humans
and mice. CMV causes acute clinical disease only if immunity is naïve or compromised, exemplifying
how coevolution with its host over millennia has resulted in a largely non-pathogenic détente. The
nature of this détente is dependent upon the many strategies that CMV uses to subvert detection by
the immune system. TNF-related cytokines are key regulators of antiviral defenses, and we have
shown that both mouse and human CMV (MCMV and HCMV) inhibit expression of the TNF-related
apoptosis inducing ligand death-receptors (TRAIL-DR) via the M166 and UL141 viral proteins,
respectively. Viral mutants lacking these proteins are highly sensitive to control by TRAIL-expressing
innate immune cells during the early-phase of CMV infection. In contrast, if MCMV is unable to restrict
TRAIL-DR signaling via M166, the duration of persistent replication is dramatically longer. This is likely
due to an altered CD4 T cell response that is unable to resolve persistence within the normal time
frame. Together, our past and new results place the TRAIL signaling system at a critical apex in
regulating various phases of the immune response to persistent virus infection. This proposal will reveal
the how this TNF-family cytokine regulates antiviral immune defenses, and will help to define their
broader importance in regulating inflammation and cell death.

Public health relevance
Project Narrative: Cytomegalovirus (CMV) is a herpesvirus that infects the majority of humans, causing serious disease if the immune system is immature or out of balance. CMV inhibits many immune signaling pathways, and we have identified viral proteins that block signaling by TRAIL, an important host immune molecule for fighting infection. The impact that CMV inhibition of TRAIL has on viral fitness, and how TRAIL regulates various aspects of CMV immunity, are the focus of this proposal.